Core A: Administrative Core

Core A provides scientific leadership that meets the EKS NICHD’s overarching mission for the IDDRCs to
advance the diagnosis, prevention, treatment, and amelioration of intellectual and developmental disabilities
(IDD). Vanderbilt Kennedy Center (VKC) IDDRC has a well-established operational structure and function that
includes continuously evaluating its leadership and oversight to meet the needs of the changing landscape of
IDD research. As such, Core A’s services have proactively evolved in a manner that has progressed with
technological advances over the 50 years of the VKC’s IDDRC. Because of this, the IDDRC has become a
successful model of integrated research, training, and service that results in a truly translational research
environment. For the next 5 years, the IDDRC’s overarching goal is to develop precision care for IDD by
providing infrastructure and scientific leadership to enable rapid translation of basic discoveries into
high-impact interventions and treatment for people with IDD. To realize this goal, the leadership of the
VKC IDDRC recognize that effective administrative oversight through Core A is critical. To this end, the
primary aims of Core A are to: (1) provide scientific leadership and administrative/financial oversight of the
IDDRC’s Signature Research Project and research cores in order to effectively meet the needs of the 50
IDDRC investigators and 70 funded research projects; (2) facilitate multidisciplinary research, recruit new
researchers to IDDRC, and maintain an educational environment to engage IDDRC investigators, trainees, and
community stakeholders; and (3) communicate and disseminate IDDRC activities targeted to
diverse stakeholder audiences. These three Aims allow Core A to provide overall scientific direction and
integration for an IDD translational research program that builds on the VKC IDDRC’s strengths in
educational, behavioral, neuroscience and approaches. More specifically, Core A helps to facilitate
interdisciplinary research by: (1) recruiting new researchers to our IDDRC from existing faculty
and via faculty recruits; (2) proactively managing fiscal and other resources, including support for
innovative IDD pilot research through the IDDRC Hobbs Discovery and Director’s Strategic Priorities Grants
and managing IDDRC space and facilities; and (3) communicating and disseminating IDD-related findings
to the broad IDD stakeholder community. Effective communications to local researchers and other
professionals combined with outstanding lay-friendly communication with the public and disability community is
a hallmark of the VKC IDDRC. Over the next 5 years, we build upon the existing excellent IDDRC
communication services to maximize targeted audience uptake by engaging stakeholders throughout the
process and incorporating dissemination and implementation science methods.
administrative glue for the IDDRC that allows for setting priorities for and overseeing
Overall, Core A is the
all of the scientific work of
the VKC IDDRC in order to meet our overall mission of improving the lives of people IDD.

Public health relevance
PUBLIC HEALTH RELEVANCE: As a group, intellectual and developmental disabilities, including Down syndrome and autism spectrum disorder, have dramatic effects on affected people’s and their caregiver’s lives. Unfortunately, there remains a lack of understanding about what causes these disabilities and, critically, how to treat them with targeted therapies. The Vanderbilt Kennedy Center’s Intellectual and Developmental Disabilities Research Center serves as the hub for Vanderbilt’s research efforts focusing on improving the lives of people with intellectual and developmental disabilities by understanding the causes of these disorders and developing and testing therapies tailored to each individual’s precise needs.